ACE INHIBITION ON PERITONEAL TRANSPORT ON PERITONEAL DIALYSIS

To determine the effect of ACE inhibition administered directly to the peritoneum or systemically on transport properties of the peritoneum in chronic ambulatory peritoneum dialysis.